SLEEP LOSS PEFORMANCE AND ERP SOURCE LOCALIZATION

The goal of the proposed research is to determine the effect of induced sleep loss on attentional processes simple auditory reaction time and event-related brain potentials. A spatio-temporal model of cortical function before and after sleep deprivation will be developed using recent advances in brain electric source analysis. It is hypothesized that sleep loss will result in a more rapid transition to deteriorated states of auditory reaction time performance across time-on-task, which will be reflected in amplitude decreases and latency shifts in the N100 and P300 waveform components of the auditory event-related potential. It is further hypothesized that cortical dipole sources will be derived from primary auditory cortex (N100) and pre-frontal association cortex (P300), resulting in a model of activity that will reveal the effects of sleep loss to be initiated in basic attentional mechanisms.